2/2 Pediatric Influence of Cooling duration on Efficacy in Cardiac Arrest Patients (P-ICECAP)

Project Summary
Out-of-hospital cardiac arrest (OHCA) in children is a tragic event that usually results in death or permanent
brain injury in survivors. More than 7000 children suffer OHCA each year in the US and improvements in
pediatric OHCA outcomes, just as in adults, is very much limited by our ability to protect the brain from global
cerebral ischemic injury in those who are successfully resuscitated. Targeted temperature management (TTM)
is currently guideline-recommended in children following OHCA with preference stated for therapeutic
hypothermia (TTM 32-34°C) over normothermia (TTM 36-37.5°C) in order to prevent fever which could amplify
brain injury. The optimal duration and patient selection criteria for therapeutic hypothermia in children remain
unknown and cooling devices are not specifically FDA approved for this indication. Preclinical data and
mechanistic studies strongly suggest that durations of hypothermia longer than those typically used in adults
may minimize brain injury. This study will determine if identifying an optimal duration (dose) of therapeutic
hypothermia can improve outcomes, and if development of a duration response curve can confirm efficacy in a
wider pediatric population of OHCA survivors. We hypothesize that longer durations of cooling will improve
survival and result in better neurologic recovery in survivors compared to shorter cooling durations, as
assessed by the Vineland Adaptive Behavior Scales–Third Edition (Vineland-3) score. The primary goal of this
project is to identify clinical strategies that will increase the number of patients with improved neurological
recovery from OHCA. The results of this trial will be extremely significant in children and will immediately
impact both clinical practice and regulatory evaluation. The Pediatric Influence of Cooling duration on Efficacy
in Cardiac Arrest Patients (P-ICECAP) trial, modeled after the ongoing adult ICECAP trial, uses innovative
adaptive dose finding methods that allow exploration of a wide range of potential durations and efficiently
allocate subjects where they will be most informative. The study will be conducted using resources of the
NHLBI/NINDS Strategies to Innovate Emergency Care Clinical Trials Network (SIREN), which is experienced
in both pediatric and adult trials, and is currently conducting the current adult ICECAP Trial. SIREN leverages
existing resources to achieve economies of scale and to conduct important clinical investigations spanning
from pre-hospital, through both the emergency department and ICU stay, and post hospital discharge.

Public health relevance
Project Narrative Pediatric cardiac arrest in the out-of-hospital setting is a tragic event that occurs in thousands of children each year in the US. Many of these children are successfully resuscitated, but most die in the hospital or are left with severe lifelong disabilities due to the brain injury that occurs during the cardiac arrest. This study plans to determine whether longer durations of cooling improve brain recovery better than shorter durations of cooling and also seeks to find the best duration of cooling for comatose children following out of hospital cardiac arrest.